Formulation, Evaluation, and Phase 0 Trial of Nanoparticle Releasing Oral Thin Film for OSCC Chemoprevention

An estimated 53,260 new oropharyngeal cancer cases and 10,750 deaths will occur in U.S. during 2020. Unfortunately, oral
squamous cell carcinoma (OSCC) is one of the most challenging-to-treat human cancers. Even if surgical resections are
curative, facial structures vital for function and esthetics are sacrificed. OSCC, however, doesn't occur de novo, but arises
from initiated keratinocytes. This pre-transformation interval provides a therapeutic window for secondary OSCC
chemoprevention. Specific situations such as tobacco and/or alcohol use or diseases associated with DNA repair deficits
e.g. Fanconi anemia (FA) can render the entire oral cavity at risk to develop OSCC. Although systemically-delivered
chemopreventives should conceptually provide full mouth field-coverage, bioavailability challenges and drug-related
systemic toxicities have generated disappointing outcomes. In contrast, local delivery formulations can deliver
therapeutically-relevant levels of chemopreventives-at markedly lower doses relative to systemic administration-to target
tissue without drug-related systemic side-effects. Notably, the oral cavity is bathed in a protective, viscoelastic, adhesive
coating hydrogel (mucous). While mucous can impede local drug delivery, mucoadhesive and mucopenetrating nanoparticle
chemopreventive formulations address this issue. Nanoparticles also function to stabilize drugs, minimize off-target side
effects, prolong chemopreventive-oral epithelial contact time and facilitate delivery to the underlying keratinocytes. The
chemopreventives for this study were selected based on our results and their complementary mechanisms of action. IL6,
produced by oral keratinocytes and other cells, is a pervasive cytokine throughout the mouth including saliva. Via its
proinflammatory, pro-proliferative and proangiogenic properties, IL6 can facilitate malignant transformation of oral
intraepithelial neoplasia to OSCC. To suppress this autocrine-paracrine loop, the IL6 receptor inhibitor, tocilizumab (TCZ)
was selected. In addition, our labs have shown that the synthetic vitamin A derivative, fenretinide (4HPR), not only
possesses growth modulatory effects, but it also demonstrates high affinity binding/inactivation of signaling kinases
upregulated during carcinogenesis i.e. FAK, Pyk2, STAT3, Wnt, c-Src and c-Abl and perturbs cytoskeletal components
necessary for OSCC cell invasion. Our data also show that while single agents are beneficial, TCZ+4HPR combination
treatment enhances the agents' chemopreventive efficacy in both in vitro and in vivo models. The Specific Aims of this
proposal are: 1) Optimize Janus nanoparticles (JNPs) for targeted co-delivery of 4HPR & TCZ to surface oral epithelium,
2) Identify the lead JNP formulation by using bioassay-based in vitro studies and an in vivo PK model., 3) Conduct a Phase
0 pharmacokinetic/ADME trial in healthy volunteers. Experimental methodology will include: electrohydrodynamic co-
jetting in conjunction with dynamic light scattering, zeta sizing and electron microscopy to formulate the JNPs, ex vivo
mucoadherence studies, in vitro monolayer and raft culture functional assays, LC-MS, IHC (quantified by image analysis),
and in vivo (rabbit model) and human clinical trial PK analyses.

Public health relevance
Project Narrative: Oropharyngeal cancer, which arises from precancerous oral lesions, will affect over 53,200 persons in the US during 2020. The best way to manage this deadly disease is to prevent precancerous lesions from becoming oral cancer. These studies will investigate a thin film that releases cancer-preventing particles throughout the mouth.